Amniotic fluid entrains embryo-wide branching morphogenesis

PROJECT SUMMARY
Amniotic fluid surrounds the embryo during development. Maintaining proper levels of amniotic fluid during
pregnancy is critical for fetal development, particularly for the lung. A reduction in the level of amniotic fluid,
also known as oligohydramnios, is associated with pulmonary hypoplasia. Human studies have indicated in
cases of low amniotic fluid levels, pulmonary hypoplasia is the strongest predictor of fetal death. Pulmonary
hypoplasia often co-presents with hypoplasia of other branched organs, but it is unknown whether the levels of
amniotic fluid directly affect their rates of branching morphogenesis. Further, it is unknown whether branching
morphogenesis is coupled across the embryo. Here, I propose to test the hypothesis that amniotic fluid
pressure or composition couples the rate of branching morphogenesis in organs across the embryo. I will test
this hypothesis by taking advantage of the observation that different mouse strains display different gestational
lengths, which my preliminary data show are inversely correlated to rate of development. In Aim 1, I will use
quantitative imaging analysis to compare the rates of branching morphogenesis in the lung, kidney, and
salivary gland (E10-E16) across four strains of mice, normalizing for chronological and morphological ages. In
parallel, I will measure the levels and physical properties (volume, osmotic pressure, viscosity) of amniotic fluid
over developmental time in each strain. In Aim 2, I will directly test the effects of pressure on the rate of
branching by culturing lungs, kidneys, and salivary glands from each strain in an innovative microfluidic culture
system to control luminal pressure. Additionally, I will perform mismatched pregnancy experiments in mice,
implanting embryos from short and long gestation mouse strains to evaluate the influence of maternal-
contributed amniotic fluid to the rate of development. In Aim 3, I will assess potential role(s) for three specific
morphogens (SHH, TGF-a, FGF8) in transducing mechanical force to influence the rate of branching
morphogenesis. Completion of the aims in this proposal will not only further our understanding of amniotic fluid
forces during embryonic development but also lay the groundwork for novel therapeutic strategies to mitigate
developmental disorders linked to amniotic fluid imbalances. This proposal will be completed in Dr. Celeste
Nelson’s laboratory at Princeton University, a top-tier research institute with state-of-the-art research facilities
and exceptional training opportunities. Dr. Nelson has extensive experience in mentoring postdoctoral
associates, and her lab offers an ideal environment to achieve the scientific goals outlined in this proposal.
During this project, I will enhance my written and oral communication skills, gain experience in teaching and
mentoring students, and further develop as a scientist. Additionally, accomplishing these aims will expand my
research expertise in mechanobiology and bioengineering.

Public health relevance
PROJECT NARRATIVE Low levels of amniotic fluid, a condition known as oligohydramnios, results in underdeveloped lungs and kidneys in humans and mice. The lung, kidney, and salivary gland have tree-like epithelium, which is formed through a developmental process called branching morphogenesis. Here, I will combine mouse genetics with state-of-the-art microscopy and novel microfluidic devices to directly test whether amniotic fluid couples organ development across the embryo.